The Center for Research, Health, and Social Justice

PROJECT SUMMARY – OVERALL
Arkansas, located in the Southern region of the United States, ranks among the lowest in the nation in overall
health outcomes and in cancer and cardiovascular disease (CVD). Within Arkansas, place- and race-based
disparities are quite profound, and rural residents and Blacks/African Americans fare the worst. Forty one-
percent of Arkansans live in rural areas where socioeconomic distress, chronic disease risk factors, and social
structural factors underlying these disparities have not changed in decades. Poverty and food insecurity are
higher, and wages, employment opportunities and health care access are lower in rural than in urban Arkansas.
Blacks/African Americans have the highest cancer and CVD mortality rates, the worst socioeconomic indicators,
and have experienced enormous historic trauma, particularly in the Delta regions. To address this historical
embedment of place- and race-based health inequities in Arkansas, the proposed Center for Research, Health,
and Social Justice (CRHS) will use a social justice framework to inform the development and implementation
of a robust process for advancing novel multilevel and transdisciplinary research, engaging communities in
equitable partnerships to address the root causes of chronic disease disparities, and building, training and
mentoring a diverse and competent research workforce prepared to eliminate disparities in cancer and CVD.
Our social justice framework will help the CRHS identify interconnected patterns of systematic disadvantage in
the community and in our research ecosystem to inform how the cores, research projects, advisory boards, and
our broad-based coalition of academic and community partners can work synergistically to accomplish CRHS
goals. Our coalition of stakeholders includes partners in the Northwest, Highlands and Delta regions of Arkansas
and multiple institutional partners integrated into the cores and research projects who will employ common
measures, tools, methods, and approaches to accomplish the CRHS goals. The CRHS will work with the NIMHD
Chronic Disease Disparities Coordinating Center to leverage and share resources, engage in cutting-edge cross
center research, and increase networking and research opportunities for new investigators. The CRHS will
leverage multiple federally-funded resources including the Clinical Translational Science Award program, the
National Research Mentoring Network, federally funded center grants, and federal surveys to help facilitate
research, training, mentoring, dissemination, and translation of research to inform public practice and policy.
CRHS builds on our prior successes and will create a robust research ecosystem that serves as a national model
for eliminating chronic disease disparities by using a social justice framework for research, training, and
community engagement.

Public health relevance
NARRATIVE – OVERALL The Center for Research, Health, and Social Justice (CRHS) will use a social justice framework to conduct research, engage communities, and build a diverse and competent research workforce to reduce disparities in cancer and cardiovascular disease. Social justice focuses on improving lives and wellbeing of historically marginalized and oppressed groups that face racism and discrimination. The CRHS is designed to become a national model for eliminating chronic disease disparities using social justice informed research, training, and community engagement.